Darwinian Evolution of Virtual Organisms

We have constructed a model of the evolution of virtual organisms. In the initial version of the model, the "organisms" are boolean networks, whose structure is specified by a "genome" which is heritable but subject to mutation. Each network is stepped through a "life cycle" in which the "task" is to generate, as closely as possible, a target function specified by the investigator. Organisms are selected for their accuracy in carrying out the task. This resulted in the evolution of organisms that were highly effective at simulating the target function. When organisms were subjected to environmental perturbation, in the form of injected, numerical noise, they could, under some circumstances, adapt by developing the ability to exclude the noise. However, we unexpectedly discovered that, under other cirumstances, organisms would adapt by incorporating extrraneous and irrelevant features of the noise into their own structure, such that it became enmeshed in the function of the organism and necessary for its function. This process, which we dubbed "noise imprinting" appears to be analogous to many situations in which extraneous elements are entrained into human culture during the process of cultural evolution. In the current project period, we have parallelized the model and implemented it on Beowulf clusters (Biowulf at NIH Bethesda, and a dedicated 48-processor cluster in our lab) increasing computational power by 2-3 orders of magnitude. Using this added power, we are constructing a model of the co-evolution of "organisms" and "memes" ("cultural" elements) the latter of which replicate by spreading among the organisms and act as "software" to control the organisms' interactions with the environment, analogous to the co-evolution of the human genome and human culture. We hypothesize that this two level evolutionary process may have consequences analogous to "group selection" among the organisms. We speculate that the evolving memes may divide into "rational" ones that act in the short term on the basis of empirical infromation from the environment and "mythological" ones that embody permanent, non-observable "truths" about the evolutionary process itself that are of value in supporting survival of the organisms over multi-generational time scales. This might provide an analog of the "scientific" and "religious" cultural elements that co-exist in all human societies.